Targeting the Stroma for Pancreatic Cancer Treatment

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDAC) remains one of the deadliest malignancies despite the recent
paradigm shifting success of immunotherapy noted in many other tumor types. Neoadjuvant strategies in PDAC
provide a distinctive opportunity for therapeutic intervention to decrease systemic recurrence, yet this remains a
substantial problem for patients undergoing curative intent surgery. The significant desmoplastic stroma,
immunosuppressive and T cell barren tumor microenvironment (TME) are obstacles for immunotherapeutic
efficacy in PDAC. Yet, the neoadjuvant approach offers a unique advantage for comprehensive and robust
analysis of the TME and stroma. This proposal describes a career development plan coupled with a parallel
research strategy carefully designed through a neoadjuvant translational approach. This approach is specifically
proposed in order to cement an independent career as a leader in translating novel findings of stromal and TME
biology into future science-driven clinical trials in PDAC. As an oncologist focused on pancreas cancer, the
applicant’s long-term goals are to become a leader in the field of pancreatic cancer with an expertise in translating
findings from collaborative laboratory research and patient biospecimen analysis. This mentored Career
Development Award proposal is based on a continued focus from previous extensive preclinical and clinical work
by the applicant, surrounding a master regulator of the TME, known as focal adhesion kinase (FAK). This
proposal is also grounded on a hyperfocus in opportunities for deeper clinical-translational experimental learning,
expert mentorship, and intensive didactics that will inform future bedside-to-bench-to-bedside investigation and
translation. The proposed work will be conducted under the exceptional mentorship of Dr. Lei Zheng and Dr.
Stephen J Pandol, international leaders in pancreatic cancer research. The environment of the Johns Hopkins
Sidney Kimmel Comprehensive Cancer Center, the Bloomberg Kimmel Institute for Cancer Immunotherapy and
the Pancreatic Cancer Precision Medicine Center of Excellence is an optimal setting from which the proposed
studies can originate novel findings and develop an independent investigator. This five year proposal
encompasses: (1) the conduct of a clinical trial to evaluate intratumoral T cell infiltration, clinical response and
safety of immunotherapy with anti-PD-1 antibody, pembrolizumab, with or without FAK inhibitor (FAKi),
defactinib, following neoadjuvant chemotherapy in subjects with high-risk resectable PDAC, (2) employing a
novel multiplex immunohistochemistry technique to examine TME immune mechanisms underlying the response
and resistance of pembrolizumab and defactinib, and (3) the investigation of the impact of pembrolizumab with
and without defactinib on fibroblast phenotypes and immunomodulation associated with reactive oxygen species
in the TME utilizing RNAseq and tumor/fibroblast co-culture. The ultimate goal of this proposal is to be able to
generate new hypotheses and develop innovative treatment approaches for patients with PDAC.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer remains a deadly and treatment resistant malignancy in large part due to significant stromal desmoplasia and an immunosuppressive tumor microenvironment (TME). This proposal seeks to elucidate if targeting a master regulator of the TME, focal adhesion kinase, can alter the stroma and immunosuppressive TME in order to sensitize pancreas cancer to immunotherapy. By employing a neoadjuvant translational research strategy combined with expert mentorship, hands-on training and intensive didactics, these challenges of pancreatic cancer can be addressed with the ultimate goal of reversing the grim clinical outcomes of patients with this deadly disease.